2025 IGF and Insulin System in Physiology and Disease Gordon Research Conference and Gordon Research Seminar

Abstract
The Gordon Research Conferences (GRCs) stand at the forefront of fostering innovative, unpublished research.
This esteemed conference unites leading scientists, emerging scholars, and students, dedicated to advancing
our understanding of the Insulin-like Growth Factor (IGF) axis—a critical regulator of development, aging, and
metabolism, and its dysregulation's link to diseases such as cancer, diabetes, and cardiovascular conditions.
The 2025 conference is set to delve into the dual nature of IGF-1, exploring its beneficial and detrimental effects
across life stages and seeking interventions to address existing knowledge gaps. It uniquely focuses on the
endocrine, paracrine, and autocrine roles of IGF and insulin, aligning with the NIDDK’s objectives to cover a
spectrum of topics from receptor signaling to its impact on gene activity in metabolic organs. A key feature of this
conference is its focus on the latest research on IGF/insulin's role in inflammation, metabolism, stem cell
influence, and its connection to health span and cancer. The inclusion of clinical experts to discuss new human
mutations within the IGF axis marks a significant addition to this year's agenda. Objectives of the conference
include promoting comprehensive dialogue among experts and newcomers, encouraging global collaboration
across continents, and advancing junior investigators through mentorship and networking opportunities. These
objectives are meticulously integrated into the conference structure, from Power Hours focusing on diversity and
inclusion to career development workshops and intimate sessions with leading experts. The impact of the 2025
IGF GRC extends beyond scientific discourse; it is a vital incubator for innovation, mentorship, and professional
development within the NIDDK community. By emphasizing open dialogue, collaboration, and inclusivity, the
conference aims to catalyze groundbreaking research and future advancements in IGF and insulin research. It
underscores the importance of community, collaboration, and career development in propelling scientific
progress, making it a pivotal event for shaping the future trajectory of IGF-1 and insulin research.

Public health relevance
NARRATIVE: Held once every 2 years, The Insulin-Like Growth Factors (IGF) and Insulin System in Physiology and Disease Gordon Research Conference (GRC) plays a pivotal role in defining the future trajectory of IGF and insulin research. The 2025 IGF GRC focuses on the concept of antagonistic pleiotropy of IGF, highlighting its dual role as beneficial in early life yet potentially harmful during aging. The conference aims to explore the complexities and challenges involved in targeting the actions of IGF.